Modifying the Single Domain Antibody Framework as Platform for Enhanced Radiotherapy

PROJECT SUMMARY
Targeted radiotherapeutics are an emerging class of highly effective treatments that leverage the potent
therapeutic properties of radiation in a biologically focused manner to provide systemic killing of cells of interest
with reduced non-target toxicity. These therapies have been utilized in cancer, inflammatory, degenerative and
hyperproliferative diseases with great clinical efficacy. There are currently, however, two main limitations of
targeted radiotherapeutics. The first is that the choice of targeting molecules is limited to a select number of
peptides and small molecules. This is driven in large part by the second limitation, which is that a targeting
molecule must have specific pharmacokinetic and pharmacodynamic properties that are not provided by
traditional antibody targeting moieties. A targeted radiotherapeutic must combine high affinity and specificity for
its target with rapid binding and blood clearance in order to minimize the radiation delivered to the bone marrow
and clearance organs. A new class of antibodies, termed nanobodies, offers a combination of high affinity binding
in a low molecular weight vector that endows rapid blood clearance by renal filtration. Nanobodies are growing
in clinical use, however to date most have been derived from the immunization of dromedaries. Immunization-
generated nanobodies have been demonstrated to have high retention in the kidneys, which is thought to be
driven by a large number of positively charged amino acids in their framework that lead to endocytosis in the
proximal tubules of kidneys. The inherent dependency of the tertiary structure of a nanobody on its primary
sequence poses significant challenges to modifying the positively charged amino acids in existing nanobodies.
Given these limitations, we have developed a novel nanobody framework that has greater than 90% reduction
in kidney retention. This framework will serve as the basis of our proposal, in which we will test the hypothesis
that reduced kidney retention can improve the therapeutic index of targeted radiotherapy. Additionally, we will
explore whether previously isolated nanobodies from immunizations can have their complementarity determining
regions engrafted into this framework. Nanobodies will also be designed to incorporate a sortase tag that allows
for rapid and facile site-specific conjugation to bifunctional chelators for both imaging and therapeutic
radionuclide incorporation. The radiolabeled nanobodies will be assessed in vitro for affinity, specificity and
stability prior to in vivo PET imaging and radiotherapy studies. Overall, this proposal has the potential to generate
a novel method for generating nanobodies with ideal pharmacokinetics for radiotherapy against virtually any
target.

Public health relevance
PROJECT NARRATIVE Targeted radiotherapeutics offer significant promise for selectively killing many types of cells involved in cancer, inflammatory and hyperproliferative diseases. Delivery agents are currently limited by a lack of robust discovery platform that allows for tunable pharmacokinetics and pharmacodynamics. The aim of this proposal is to develop a novel modular system for generating nanobodies with improved pharmacokinetics that can be used to develop higher therapeutic index radiotherapeutics against a variety of disease-causing cells, with the potential to significantly expand the clinical impact of this class of treatment.